AFC-HDPTP

AFC HDPTP Project Summary
A disaster, by definition, is an unexpected destructive event that brings harm and damage to a
community. While the community members often feel powerless to control the disaster, they can take steps to
prepare for their response if it occurs. AFC proposes to use funds from the NIEHS Worker Training Program’s
Hazmat Disaster Preparedness Training Program (HDPTP) to provide preparedness training to public safety
responders in the southeast US and to Native American tribes throughout the country. The proposed project
will continue AFC’s ten-year history with of delivering quality training focused on safety for first responders to a
disaster, whether natural or man-made. This project will target public safety (fire, law, EMS, EMA) responders
with training that helps them recognize hazards, assess response actions, and bring some order to the chaos
of the disaster scene. Disasters often become mass casualty incidents (MCI) and responders may need triage
their limited resources to do the most good. Also, unfortunately, these MCI events may be “man-made” acts of
terror in which the perpetrator of violence is still at the scene. AFC proposes to bring Hostile Event Response
training that teaches enhanced situational awareness and survival as well as life-saving tactical “stop-the-
bleed” care in an active shooter or improvised explosive device event. AFC projects to bring a total of 70
classes to 1,400 trainees in 11,200 contact hours. It will be split between both the public safety and Native
American target populations.

Public health relevance
Component Project Summary Not Required